Oregon HIV/HCV and Opioid Prevention and Engagement (OR-HOPE)

Project Summary / Abstract Oregon HOPE COVID-19 Supplement Request Document not applicable to proposal.

Public health relevance
Project Narrative Oregon HOPE COVID-19 Supplement Request Document not applicable to proposal.